Mechanisms of cerebral infarcts and brain oxygen utilization in anemia

PROJECT SUMMARY
While cerebral oxygen delivery depends on the cerebral blood flow (CBF; ml blood/100g tissue/minute) and
blood oxygen content, it is becoming increasingly recognized that blood capillary transit time itself can also
influence tissue oxygen extraction, even in the presence of normal or elevated CBF. In individuals with
anemia where accelerated capillary flow velocities may be present as a result of hyperemia and
cerebral autoregulation, reduced capillary transit time can lead to reduced times for tissue oxygen
offloading. Compelling evidence has been provided for heterogeneous capillary flow underlying abnormal
oxygen delivery in multiple conditions including expansion of infarcts in acute ischemic stroke, traumatic brain
injury, and Alzheimer's disease. In sickle cell anemia (SCA), we have observed that rapid capillary transit,
visible on arterial spin labeling (ASL) CBF-weighted MRI, is present in more than 50% of adults and children.
We have shown in published work and preliminary data from 154 adults and children with SCA that
hyperintense ASL signal within cerebral dural venous sinuses is directly associated with elevated arterial
velocities, elevated CBF, and reduced oxygen extraction fraction (OEF; ratio of oxygen consumed to oxygen
delivered), and that this effect may reduce following transfusion therapies that improve oxygen delivery to
tissue. These findings indicate that venous hyperintense signal on ASL images may represent a marker of
capillary-level disturbances in oxygen exchange efficiency. One of the most impactful findings of our
preliminary work is that we have observed that rapid capillary-level arterio-venous transit is associated
with reduced oxygen metabolism, suggesting that these transit times may provide a biomarker of
cerebral ischemia in individuals with SCA who have greater than a 50% risk of cerebral infarcts by age
30 years, yet often lack conventional stroke risk factors. Here, we propose to refine neuroimaging
methods for evaluating arterio-venous transit to allow for robust, quantitative measures of capillary transit time
non-invasively in vivo, and subsequently to test fundamental hypotheses regarding cerebral oxygen utilization
in anemic individuals with vs. without infarcts. Aim (1): To apply innovative ASL MRI methods and time
regression analyses over major intracranial arteries and dural sinuses in healthy control and SCA participants.
Aim (2): To quantify cerebral capillary transit time in SCA participants before and after treatment with blood
transfusion to understand how increases in hemoglobin parallel an improvement in brain oxygen extraction.
Aim (3): To test the hypothesis that arterio-venous transit times are reduced in individuals with SCA with
versus without infarcts. The short-term goal is to utilize non-invasive imaging approaches to understand
mechanisms of oxygen utilization and neurovascular dysfunction in anemia. The long-term goal is to
use this information to triage individuals with anemia for personalized stroke prevention therapies, as
well as to objectively quantify the impact of these therapies on brain health.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE Individuals with profound anemia, particularly sickle cell anemia (SCA), have a high risk of developing strokes and silent cerebral infarcts; this risk begins in early childhood, with more than 50% affected by 30 years of age. Better understanding stroke mechanisms in anemia should improve stroke risk identification, and lead to better treatments to prevent stroke. This study uses multiple hemodynamic and metabolic brain imaging techniques to understand differences in brain blood flow and oxygen use before versus after anemia treatments, as well as how brain blood flow and oxygen utilization differ in anemic individuals with versus without strokes.